Dysregulated cell-type specific gene regulatory networks underlying alcohol dependence

Alcohol use disorders is a complex polygenic disease. Cell-type specific data from medial prefrontal cortex (mPFC) from alcohol-dependent mice shows dysregulated gene co-expression networks and transcription factors. This proposal tests the hypothesis that genetic rescuing of dependence-dysregulated gene regulatory networks and co-expression modules will result in reversing escalated alcohol use. The proposal tests this hypothesis in three specific aims: Aim 1 (K99): To test the effect of genetic rescuing an astrocytic dependence-upregulated gene co-expression module on escalated alcohol drinking through performing parallel perturbations of the top connected hub genes of the module. This aim will assess the contribution of gene co-expression modules to alcohol drinking phenotype; Aim 2 (K99): To identify cell-type specific dependence-dysregulated chromatin accessibility and gene regulatory networks. This aim will allow for the (a) construction of cell type-specific gene regulatory networks through connecting cell type-specific chromatin accessibility to gene expression data in alcohol-dependent and control samples, allowing for the identification of alcohol-dysregulated gene regulatory networks, Aim3 (R00): To reverse alcohol escalation through rescuing alcohol-dysregulated gene regulatory networks. This aim performs global non cell-type specific perturbation of a set of transcription factors in alcohol-dependent mice followed by characterization of the resulting changes in alcohol-drinking phenotypes. Dr. Nihal Salem’s goal is to be an independent researcher in the field of alcohol research and to develop a research program that spans genomics, bioinformatics, and functional studies linking transcriptomics to alcohol drinking phenotypes. This proposal outlines a research and training plan to provide Dr. Salem with two years of mentored postdoctoral training and three years of support to start her independent research direction.

Public health relevance
Project Narrative Alcohol use disorder is a chronic, relapsing brain disorder characterized by an impaired ability to stop or control alcohol use despite adverse consequences. This project will use a mouse model of alcohol dependence to pinpoint gene networks that contribute to increased alcohol intake. This project will genetically target these networks to decrease alcohol drinking.